VZV vaccine attenuation and the DNA damage response

ABSTRACT
Diseases caused by the human herpesvirus Varicella Zoster Virus (VZV) are widespread and debilitating but
can be limited by using live attenuated VZV vaccines. The varicella vaccine has been hugely successful in the
US, but many countries do not use it widely, some not at all. A high titer version of the same vaccine virus was
then developed to immunize adults to boost VZV immunity and reduce the incidence of Herpes Zoster (HZ),
the result of VZV reactivation from neuronal latency. HZ is debilitating and complicated, most often by chronic
pain that is difficult to treat. HZ remains a public health concern, because most adults harbor wild-type (WT)
VZV in their ganglia and are at risk for HZ, and the HZ vaccines have far from optimal coverage in the target
populations. The live vaccine virus, vOka, needs improvement. It can cause rashes, go latent and cause rare
cases of HZ. It is genetically heterogeneous, with hundreds of single nucleotide polymorphisms (SNPs)
occurring at different parent/vaccine allele frequencies. The basis of virus attenuation is not known. 5 SNPs are
fully or nearly fully fixed for the vaccine allele and are suspected to direct attenuation. Intriguingly, four lie in
the VZV gene encoding IE62, a critical protein that regulates expression of all VZV genes. Excitingly, our data
shows that WT VZV, through its IE62, turns on expression of the stem cell epidermal marker KRT15 in
keratinocytes and skin, while vaccine virus and its IE62 do not. We then found that KRT15 expression in our
epithelial differentiation model is required for VZV replication. Furthermore, KRT15 levels influence the
keratinocyte DNA Damage Response (DDR). Taken together, the data support a global hypothesis that IE62
upregulates KRT15 to control pro-viral aspects of the DDR. vOka is attenuated in skin because its IE62 does
not trigger the upregulation of KRT15 to regulate DDR pro-viral pathways. To test this hypothesis, Aim 1 will
seek to establish that vaccine SNPs in IE62 underlie growth attenuation in models of skin. First, we will use a
complementation assay to delineate those vaccine SNPs that prevent IE62 from boosting the replication of
vOka vaccine virus in keratinocytes. Second, we will develop WT VZV recombinants that contain ORF62
genes with vaccine SNPs, then quantify their replication in models of skin, including human skin explants. In
Aim 2, we will characterize steps of the novel IE62-KRT15-DDR pro-viral pathway that is differentially regulated
by KRT15 levels and IE62. This includes studying how the IE62 vaccine genotype influences KRT15
transcription; how KRT15 levels affect the DDR and VZV replication; and what components of the DDR are
proviral for VZV in the human epithelial differentiation model. Aim 3 will seek to determine if IE62 specific
SNPs underlie the poor reactivation phenotype of vOka from neuronal latency, using cultured human neuron
models that have successfully modeled VZV latency and experimental reactivation. Together, these studies will
define mechanisms governing VZV attenuation and establish foundations for generating a defined
homogeneous live vaccine candidate that is attenuated in skin and unable to reactivate from the latent state.

Public health relevance
NARRATIVE Live attenuated vaccines based on the same genetically heterogeneous virus are used to reduce chickenpox and zoster, but the basis of skin attenuation is unknown. The vaccine can be problematic in some recipients because it is genetically a mix. The work proposed here will show that attenuation involves changes in a VZV regulatory protein that influences DNA repair. The results may lead to a more defined vaccine candidate.